The Impact of STING Activation and Fever on Regulatory T cell Function and Stability

Project Summary
The cGAS/STING pathway is an essential mediator of many anti-viral and anti-tumor immune responses
because it senses cytosolic double stranded DNA (dsDNA), which can accumulate as a result of infection, tumor
cell death, or cell stress-induced DNA leakage from the nucleus or mitochondria. STING interacts with metabolic
regulators of T cell activation, differentiation, and plasticity, and was recently shown to promote CD4+ T cell
differentiation into inflammatory Th1 and Th9 cells with enhanced functions. There are almost no reports of
STING activation in regulatory T cells (Tregs), which have an opposing, but crucial, role in suppressing excessive
inflammation. Inflammation can also coincide with elevated temperatures (i.e. fever-range temperature, FRT,
39°C), which can cause self-DNA leakage, yet the effects of FRT on STING in Tregs are unknown. Tregs have
a unique capacity to be reprogrammed into inflammatory effector-like cells by an increase in glycolysis, which
suppresses the lineage-driving transcription factor FoxP3, and in turn, inhibits their suppressive function. The
goal of this research is to dissect the mechanisms intertwining STING activation and FRT and their effect on
Treg function and metabolism. We propose to accomplish this through two Specific Aims: 1) We will establish
the effects of STING activation at physiological temperatures on Treg function and metabolism. We will first
profile transcriptional and epigenetic changes in STING-activated Tregs to unbiasedly identify mechanisms
underlying the phenotype observed in our preliminary data. Effector functions of STING-activated Tregs will be
evaluated in vitro and in vivo. Metabolic reprogramming will be assessed in vitro by performing metabolic flux
analyses of STING-activated Tregs and comparing the effect of metabolic inhibitors on STING-activated Treg
function. 2) We will investigate the effect of FRT on STING activation in Tregs via functional and metabolic
analyses. We will first determine if FRT alone activates the cGAS/STING pathway in Tregs. We will then test if
the effects of FRT in Tregs are dependent on cGAS/STING by evaluating Treg phenotype, function, and
metabolism at FRT in cGAS and STING deficient cells. The impact of FRT on STING activation in Tregs will be
investigated by treating Tregs with a STING agonist at 37°C and 39°C and comparing their gene expression,
suppressive versus inflammatory function, and metabolism in vitro and in vivo. Given that STING can increase
in glycolysis in innate cells, we hypothesize that STING activation induces a glycolytic switch in Tregs that inhibits
their suppressive function and reprograms them into inflammatory Th1/Th9-like cells, and that this is potentiated
at FRT. This research will define the role of STING in Tregs at physiological and fever temperatures, motivate
further investigation of immune cell function in the context of inflammation, and has the potential to identify Treg-
intrinsic STING activation as a novel approach to improve T cell responses for vaccines and immunotherapies.
This proposal describes a multidisciplinary and rigorous co-mentoring and training plan that has been
personalized to ensure the success of this project and the applicant as an independent research scientist.

Public health relevance
Project Narrative The cGAS/STING pathway and regulatory T cells (Tregs) share essential but opposing roles in many inflammatory immune responses – which often coincide with elevated temperatures (e.g. fever-range temperature, FRT) – yet the mechanisms intertwining FRT and STING activation in Tregs remain unknown. This proposal aims to establish the individual and combined effects of FRT and STING activation on Treg function and metabolism. We hypothesize that cGAS/STING pathway activation glycolytically reprograms Tregs into inflammatory T cells and that this is potentiated at FRT during inflammatory immune responses.